Epidemiology and Biomarkers in Transplant Associated Thrombotic Microangiopathy (TA-TMA): A Prospective Validation Cohort Study

Project Summary/Abstract
Approximately 10,000 patients receive an allogeneic hematopoietic cell transplantation (HCT)
annually in the United States. Transplant-associated thrombotic microangiopathy (TA-TMA) is a
rare but often fatal hematologic complication that manifests with uncontrolled microangiopathic
hemolytic anemia (MAHA), thrombocytopenia, microvascular thrombosis, and in severe cases,
permanent neurologic or kidney dysfunction. We recently completed a large retrospective cohort
study to elucidate the incidence of and clinical risk factors for TA-TMA. Building upon the
previous experience, our objectives in the current proposal are to test these clinical predictors
and laboratory biomarkers associated with TA-TMA development in an independent prospective
pediatric cohort to improve early detection and risk stratification. We propose the following aims:
Aim 1: To determine the incidence and early post-transplant risk factors for TA-TMA in a
prospective pediatric cohort study that incorporates the use of clinical informatics. Aim 2: To test
a dynamic risk prediction tool for TA-TMA that incorporates validated clinical and laboratory
biomarkers in immune, endothelial, and complement activation pathways.
The K23 award applicant, Dr. Ang Li, is well-qualified to conduct the proposed project. He is
committed to becoming an independently funded patient-oriented physician scientist in benign
hematology. He has proposed a comprehensive five-year career development plan to help his
transition from supervised research to independence. Specifically, he envisions a strong
mentorship panel, a formal advisory committee, a realistic coursework training in epidemiology,
biostatistics, clinical informatics, and bioethics. The Section of Hematology (primary affiliation)
and Section of Epidemiology and Population Sciences (secondary affiliation) at Baylor College
of Medicine offer an ideal research training environment and the Institution is fully committed to
his career development.

Public health relevance
Project Narrative Transplant-associated thrombotic microangiopathy (TA-TMA) is an often-fatal hematologic disorder without an effective treatment currently. This project aims to provide a better understanding of the epidemiology and risk factors for this rare disease and to design and test a dynamic risk prediction tool through a prospective cohort study. Results of this proposal will be helpful to the understanding of the disease and the design of future interventional trials.